Biostatistics and Bioinformatics Core

PROJECT SUMMARY
Biostatistics and Bioinformatics Core (Shared Resource)
TUFCCC: Eric A. Ross, PhD (Co-Leader) HC: Konstantinos Krampis, PhD (Co-Leader)
The overall goal of the Biostatistics and Bioinformatics Core (BBC) is to facilitate cancer
disparities research at TUFCCC and HC by providing expert experimental design,
bioinformatics, data management, genomics and data analysis support to TUFCCC/HC Cancer
Partnership scientists. Members of the core have substantial knowledge and experience in
biostatistics, bioinformatics, genomics and epidemiology as applied to cancer research. This
highly interactive group of biostatisticians, bioinformatics, informaticians, geneticists and
epidemiologists will serve all Partnership projects, pilot studies and cores and support future
projects and pilot studies.
The specific aims of the Biostatistics and Biostatistics Core are to: (1) Provide expert
consultation for TUFCCC/HC Cancer Partnership investigators in the rigorous design of
experiments and studies, including research proposal development, sample size determination,
randomization procedures, experimental methods and plans for interim reviews and final
analysis. (2) Perform statistical and bioinformatics analyses for TUFCCC/HC Cancer
Partnership investigators using appropriate statistical and computing methodologies, as well as
assist investigators with the writing of statistical and bioinformatics components of manuscripts
and the interpretation and presentation of results. (3) Provide Informatics tools to enhance
TUFCCC/HC Cancer Partnership research. Build cancer research capacity at HC by providing
HC researchers with information systems that facilitate data entry, storage and retrieval. (4)
Provide cost-effective, high-quality genomic and epigenetic services and expertise for the
TUFCCC/HC Cancer Partnership including NextGen sequencing (e.g., DNA-Seq, RNA-Seq) as
well cytogenetic analysis, chromosome and expression microarray solutions as needed. (5)
Enable TUFCCC/HC investigators who may be non-technical users to easily access and
manage large-scale genomic datasets and run bioinformatics data pipelines, through a user-
friendly, web-browser accessible interface.
By providing quantitative and genomics expertise and resources to investigators, and sharing
technical capabilities, the BBC team will support the entire TUFCCC/HC Cancer Partnership
and facilitate achievement of project aims and exploratory analyses beyond those stated.

Public health relevance
PROJECT NARRATIVE Biostatistics and Bioinformatics Core (Shared Resource) Leveraging the strengths and resources of the two institutions (TUFCCC and HC), the Biostatistics and Bioinformatics Core is dedicated to the accumulation, management, distribution, analysis and interpretation of information generated by this TUFCCC/HC Cancer Partnership. Core members will apply their knowledge and skills of quantitative, computational and genomics methods to facilitate and enhance cancer health disparities research and cancer education in PA, NJ and NYC region.